Undergraduate and Graduate Training in Computational Neuroscience and Data Analysis

Project Summary
The goal of this training program entitled “Training in Computational Neuroscience and Data Analysis” is
to help undergraduate and predoctoral students gain the knowledge, skills, and attitudes they need to
flourish in a scientific career that brings quantitative approaches to the study of neuroscience and
behavior. This new program arises from a prior training program in Computational Neuroscience at
Brandeis University that expired recently after 10 years of NIDA support. Given the increasing
importance of machine learning in data analysis and solving of data-rich scientific problems, coupled with
recent Brandeis hires in the field, our new program will include more participation from computer science
faculty with expertise in the field. Also, given the recent introduction of an applied mathematics major at
Brandeis and associated new faculty in the field, we have doubled the number of training labs with
students working on mathematical modeling in neuroscience. The proposed program requests funding
to support 6 undergraduates, 4 NRSA eligible graduate students, and 2 non-NRSA eligible graduate
students each year. We will target two cohorts of prospective trainees: 1) Individuals with strong prior
experience with quantitative methods who wish to work in neuroscience. 2) Individuals with backgrounds
in psychology, neuroscience and biology who wish to learn to employ quantitative and computational
methods to tackle important problems in neuroscience. We will continue prioritizing outreach activities
aimed at ensuring trainees from underrepresented populations are included in our program. Students will
have two complementary mentors so they participate in labs with both quantitative and experimental
approaches to neuroscience. The 26 training faculty have research expertise ranging from human
cognition to cellular and molecular neuroscience, so a wide variety of research problems, at numerous
levels of analysis are available to trainees. The training faculty were chosen based on demonstrated
commitment to the use of theoretical and computational methods and interdisciplinary collaboration to
understand the nervous system in health and disease. Students will take courses in statistics, data
analysis, computational neuroscience, obtain skills in building models of neurons, synapses, and
networks, and employ these in a variety of independent research projects. In addition to course work and
laboratory research, students and trainees will be engaged in a large number of other activities designed
to enhance their speaking skills, writing skills, and ability to collaborate with other scientists. All students
and trainees will receive training in the responsible conduct of science and will interact with senior
scientists at other institutions.

Public health relevance
Project Narrative Alleviating the burden of neurological and psychiatric disorders will require a cohort of investigators who can use computational and theoretical tools to understand brain function in health and disease. This program will train undergraduates and graduate students to use quantitative modeling combined with advanced statistical and machine learning methods for analysis of large datasets to reveal features of brain function and disease not possible without these quantitative approaches.